PULSATILE VS CONTINUOUS PITUITARY SIGNAL FOR GONADAL STEROIDOGENIC RESPONSE

This study will determine if the pulsatile nature of the endogenous LH signal (i.e., the episodic release of LH under physiological conditions) has a major influence on gonadal production of sex steroid hormones in men and women using GNRH antagonist.